Spatial organization and conformational ensembles of amyloids inside cells

Project Summary
The formation of intracellular inclusions containing fibrillar aggregates of alpha-synuclein
(α-syn) is a hallmark of neurodegenerative diseases such as Lewy body dementia, Parkinson’s
disease, and multiple systems atrophy. An intrinsically disordered monomer, α-syn, can
assemble into various fibrillar forms influenced by its environment. Understanding the
conformations that α-syn adopts in health and disease is crucial for developing diagnostic and
therapeutic tools. Although advances in structural biology have accelerated the characterization
of isolated amyloid fibrils, it is essential to know the α-syn structures in biological settings, as
isolated fibrils may not represent in vivo conformations. Current methods, such as isolating
fibrils from post-mortem tissues or using seeding to amplify fibrils in vitro, might not capture the
prevalent in-cell conformations. This project aims to identify the amyloid conformations and their
abundances inside cells, which will enhance our understanding of amyloid propagation and aid
in identifying biologically relevant structures. We will investigate how different cellular
environments affect seeded amyloid propagation by using biosensor cell lines and neurons. In
biosensor cell lines expressing wild-type and mutant α-syn, we will introduce α-syn and assess
its aggregation into amyloid fibrils upon exposure to seeds. This approach will allow us to
compare amyloid propagation in vitro with that inside cells. In neurons, we will study the seeded
amyloid propagation of well-characterized α-syn fibrils, considering the influence of the cellular
environment on fibril formation and propagation. Understanding how specific cell types affect
amyloid propagation is crucial, as different neurodegenerative diseases involve amyloid fibrils
accumulating in distinct cell types. Additionally, we will analyze amyloid structures from tissue
seeded Lewy body dementia patients. By comparing these structures with known α-syn fibril
conformations, we aim to identify unique features and polymorphs relevant to disease
pathology. We will use a multi-scale approach with two complementary, state-of-the-art in situ
structural techniques: in-cell DNP sensitivity-enhanced NMR spectroscopy and cellular cryo-
ET/subtomogram averaging to characterize the conformational ensembles and spatial
organization of α-syn amyloids in situ. This comprehensive approach will provide insights into
the structural diversity, molecular interactions and organization of α-syn amyloids, as well as
their effects on cells, ultimately advancing our understanding of neurodegenerative disease
mechanisms and pathology, and informing the development of targeted diagnostics and
therapeutics.

Public health relevance
Project Narrative Neurodegenerative diseases such as Lewy body dementia and Parkinson's disease are characterized by the aggregation of α-synuclein into diverse amyloid fibril forms. Structural biology advancements have solved the atomic structures of many of these forms in vitro, yet their relevance to in vivo conditions remains uncertain. To understand which amyloid forms are present inside cells and what cellular factors affect aggregation, we will use a combination of in- cell DNP-enhanced solid state NMR and cryo-electron tomography to determine α-syn fibril structures inside cells and visualize their interactions with cellular components.